Driving next generation UPR inhibitory kinase inhibitors for T1D

PROJECT SUMMARY/ABSTRACT
Type 1 diabetes (T1D) is a chronic autoimmune disease characterized by hyperglycemia due to progressive
immune-mediated destruction of pancreatic beta cells. Recent work from our laboratories has shown that
hyperactivation of the unfolded protein response (UPR) to ER stress in the immune-targeted beta cells may be
a critical early event in the development of T1D. We have developed novel pharmacological reagents called
‘PAIR’s that allow us to manipulate components of the UPR. Importantly, first-generation versions of small
molecules delivered to NOD mice can efficaciously prevent and even reverse diabetes in this T1D model.
Thus, in this collaborative grant we will capitalize on the complementary expertise of the investigators to
optimize these next-generation “PAIR” molecules for potency and selectivity, conduct proof-of-concept studies
using human islets (ex vivo and in transplanted mice), and perform key enabling steps needed to advance
these candidates further into the clinic for treating human patients with T1D.

Public health relevance
PROJECT NARRATIVE Type 1 diabetes (T1D) is a chronic autoimmune disease characterized by hyperglycemia due to progressive immune-mediated destruction of pancreatic -cells. The enormous insulin protein secretion burden of -cells predisposes them to high endoplasmic reticulum (ER) stress, leading to their apoptosis. Work from our laboratories has shown that stressed -cells have high-level activation of the unfolded protein response, which may be an initial causal event in apoptosis and development of T1D, that we will intervene against with novel chemical matter called PAIRs as -cell sparing therapeutic agents.